MARC at Emory University

PROJECT SUMMARY/ABSTRACT
This is a new Maximizing Access to Research Careers (MARC) T34 to support undergraduate training at Emory
University. The proposed training builds on an expiring (ends in 2023 when the proposed MARC T34 would start)
Initiative for Maximizing Student Development (IMSD) program that combines undergraduate and graduate
programming. The proposed MARC T34 adds innovative components focused on providing undergraduate
students with inquiry-based research experiences and an inclusive, supportive community so they can complete
their baccalaureate degree, transition into, and complete biomedical, research-focused higher degree programs
(e.g., PhD or MD/PhD). Research training opportunities at Emory include a broad array of biomedical, public
health, and other STEM disciplines. An interdisciplinary academic culture and environment coupled with
extensive expertise in biomedical research makes Emory a fertile environment for training the next generation
of scientific leaders. This ambitious proposed T34 will support a cohort of 20 MARC Scholars (10 juniors and 10
seniors) starting in the summer prior to junior year through graduation. MARC activities are designed to
complement degree requirements to avoid an undue added burden on MARC Scholars. The primary activity
supporting the proposed MARC training is an existing 1-credit Professional Development Seminar, which
provides an inclusive community that bolsters scientific identity, includes skills-based learning to supplement
discipline-based training, and provides access to professional development and networking opportunities. Other
MARC training activities use evidence-informed approaches to train students in important scientific practices
such as data reproducibility and responsible conduct of research. Innovative aspects of the program include an
experienced and diverse MPI leadership team that brings distinct skills to student training, including dedicated
effort from the Senior Director of Undergraduate Research Programs. A full-time MARC Assistant Director brings
extensive experience in driving student success and retention through academic programming and counseling
to the leadership team, while a Graduate Student liaison serves as a role model and near-peer mentor. This
multi-level mentoring structure allows individualized attention to the success and wellbeing of MARC Scholars.
Furthermore, the T34 mandates annual mentor training for ALL faculty preceptors to build an inclusive research
environment. The depth of the pool of admitted students who would be eligible for T34 support combined with
the track record of training and the potential for enhanced impact provide strong rationale for this proposed
training program. The specific objectives are to: 1) recruit ~100 students from underrepresented groups at Emory
during the 5-year term of the T34 and provide these students with the tools to complete their BS degrees in a
timely fashion, proceed to a PhD or MD/PhD, and plot a successful career trajectory in the biomedical workforce;
and 2) ensure that MARC Scholars acquire agency as scientists by contributing to at least one publication, which
may be published after they graduate, and presenting their work both locally and at a national scientific meeting.

Public health relevance
PROJECT NARRATIVE This new application, which builds on success of a prior undergraduate IMSD program, requests funding to support a Maximizing Access to Research Careers (MARC) T34 at Emory University. We propose to support a diverse cohort of MARC Honors Scholars by building scientific identity and resilience while fostering scientific creativity and embracing research excellence through a structured program as well as an engaged and supportive community. The proposed research training program, which will complement, but not duplicate, requirements for students to complete their degrees will incorporate didactic, research, mentoring, and career development elements to prepare trainees for entry into and completion of research-focused higher degree programs in biological/biomedical fields.